End to End, Cold Chain Validation Using Sample Attached History Log

Abstract
Regenerative medicine therapies of various kinds are promising and rapidly growing, both in scale and type.
The therapeutic products are not pills–they are living cells that are harvested from a patient (or sometimes a cell
bank) and are shipped to a pharmaceutical company that modiﬁes the cells and then sends them back to be re-
injected into the patient. Logistics plays an outsize role in this process because the samples need to be
maintained at ultra-low temperatures throughout the shipping process. Because these samples are personalized
to a particular patient, they are not replaceable with something else. If damaged or switched, the outcome will
be dire.
The state-of-the-art shipment technology today is, a dry shipper at liquid nitrogen temperature with a
temperature logger that is physically attached to the dry shipper–but they report the temperature of the shipper,
not the sample so if a sample is removed for inspection, this will not be recorded.
For regenerative medicine therapies to be successful, it is essential that the end-to-end processes of freezing,
storage, and thawing are carried out in strict adherence to precisely deﬁned protocols. Transient warming events
and variability in product temperatures throughout shipping and distribution can negatively affect the samples
and contribute to poor clinical outcomes. Therefore, it is necessary to validate optimized cold chain practices
individually for each sample, to ensure the highest quality therapeutic outcomes.
The goal of this fast-track proposal is to develop a functional pilot product that will provide an on-the-sample,
end to end temperature log before, during, and after shipping. Software will compare user-deﬁned protocol
criteria with the sample temperature record and will provide a go / no-go decision for use of the sample.
The speciﬁc aims of the project are: (a) develop the on-sample electronics that records the temperature history
of the sample along with timestamps with an accuracy of 2 °C, (b) develop the shipper electronics that needs to
operate for 3 days on batteries and record time stamped sample temperatures and transmits that data back to the
sample custodian, and (c) develop a cryogenic container that can keep the sample data acquisition active while
the samples moving around in the lab, and ﬁnally (d) a quality assurance station the can inform the end user if
the sample is viable by checking the sample's temperature record against the criteria set by the protocols for that
sample.

Public health relevance
Narrative Regenerative medicine is a rapidly developing and promising ﬁeld of modern medicine. Cells are removed from a patient, then shipped at ultra-cold temperatures to a pharmaceutical company for modiﬁcation, shipped back and then put back into the patient. We are developing a technology that provides a cold-chain of custody for each sample so that the end user can make an informed decision about the sample's viability.